Sequence optimization for mRNA cancer therapy

SUMMARY
mRNA technology is in the public spotlight thanks to its role in fighting the COVID-19 pandemic, and it is also
rapidly transforming cancer therapeutics development through application areas such as immunotherapy. This
wave of mRNA therapeutics is the result of decades of work on many fronts including improved delivery using
lipid nanoparticles and inclusion of modified nucleosides for modulating immunogenicity. However, optimization
of primary sequences still remains a difficult yet coveted challenge due to its untapped potential in controlling
protein expression or encoding complex pharmacokinetics. Currently, mRNA therapy design typically involves
adding UTRs from highly expressed native genes such as globin genes to codon-optimized (choosing most
frequent synonymous codons) or GC content-enriched coding sequences. However, there is growing evidence
that these strategies may be conceptually questionable and empirically suboptimal. At present, there exists no
systematically validated model for mRNA therapeutics that can accurately predict and/or generate an optimal
sequence to express a given target gene at desired levels. There is a significant need for such an in silico
platform to accelerate therapy development timelines. Finally, mRNA sequences are largely chosen to have
high expression but future therapies will impose additional design specifications for controllable expression.
For example, it might be desirable to target protein expression to specific locations such as the site of a tumor.
Improved design algorithms are necessary to satisfy constraints such as cell type or tissue specificity. Here, we
propose to combine machine learning with massively parallel reporter assays (MPRAs) to build predictive
models that relate mRNA sequence to stability and translation. We will then combine these models with
innovative design algorithms to generate synthetic UTR and CDS sequences that result in (1) high protein
expression across cell types or (2) highly cell type-specific protein expression. We will take an iterative
approach to sequence design wherein we will synthesize designed UTRs, experimentally test them in a panel
of cell types and then use the data to retrain the predictors until we meet the design objective. We will validate
our approach by engineering improved mRNAs for cancer immunotherapy. In Specific Aim 1, we will develop
MPRAs that interrogate 5’UTRs and coding sequences as well as 3’UTRs. In Specific Aim 2, we will develop
machine learning approaches that enable us to integrate results from multiple measurements and generalize
predictive rules learned from such assays. In Specific Aim 3, we will validate models by engineering
regulatory elements that target protein expression to specific cell types of interest or that result in a specific
level of protein expression.

Public health relevance
NARRATIVE This research seeks to develop predictive models of mRNA stability and translation from massively parallel reporter assays. These models will be applied for engineering functional sequences for mRNA cancer therapy applications such as UTRs that result in maximal protein expression levels or target expression to specific cell types.